Data Integration and Analysis Core

Allergic diseases (asthma, allergic dermatitis (AD), allergic rhinitis, food allergy and eosinophilic esophagitis
(EoE)) commonly affect US children and have substantial lifetime co-morbidity. Our findings over the last 3
funding cycles identify and implicate novel epithelial pathways as key drivers of allergic inflammation and
allergic disease pathogenesis. However, how these key drivers and other epithelial pathways contribute to
development, persistence, progression and remission of allergic disease remains largely unknown. Our Center
is focused on refining current atopic march paradigms and elucidating the epithelial-centric mechanisms that
drive the atopic march. This proposal’s overarching hypothesis is that homeostatic mechanisms at epithelial
surfaces, upon dysregulation, promote allergic inflammation and contribute to the persistence, progression,
remission, and resolution of allergic disease(s). This hypothesis will be tested by three integrated and
synergistic projects that combine epidemiologic, basic, translational, and clinical research approaches. The
Data Integration and Analysis Core’s (DIAC) purpose is to provide the quantitative expertise to accomplish the
overall objectives, curate and integrate data, and perform synergistic analyses. The DIAC’s expertise in
quantitative genetics, genomics, statistics, ancestry, and bioinformatics enhances the capacity for rigorous and
reproducible research that will be applied to advance the goals of the overall Center as well as assist the
project investigators with their specific hypotheses and aims. This DIAC’s aims are to 1) curate, integrate, and
share data and results across the U19 Center team and with the scientific community; 2) provide analytic rigor
and expertise to the Center Projects so that the Center can achieve its overarching goal and the Projects can
achieve their goals; and 3) perform synergistic analyses across all Projects so the Center can achieve its full
potential. Our longstanding success in evaluating the role of the epithelium in allergic disorders coupled with
our MPAACH longitudinal cohort, novel experimental systems to perform mechanistic studies, and analytic
expertise, uniquely position us to accomplish the Center objectives. Successful completion of the proposed
studies will provide novel insights into a key question in the allergy field: Why is allergic inflammation restricted
to one tissue in some cases, while it progresses to involve additional tissues in other individuals?